Role of tryptophan catabolism and AHR pathways in natural resistance of Leishmania (Viannia) panamensis to antimonial drug

Pentavalent antimony has been the first-line treatment for cutaneous leishmaniasis (CL) in South America
for over four decades despite frequent treatment failure. Leishmania (Viannia) panamensis is the predominant
causative agent of CL in Colombia. Previous investigations by our research team revealed that subpopulations
of L. (V.) panamensis distinguished by their isoenzyme profiles display natural resistance (zymodeme 2.3) and
sensitivity (zymodeme 2.2) to meglumine antimoniate (Sb) in vitro. We have also recently shown that CL caused
by naturally resistant 2.3 strains present a significantly higher rate of treatment failure (63%) than CL caused by
sensitive 2.2 strains (31%). Transcriptome-based sequencing analysis revealed that human macrophages
infected with naturally resistant subpopulations of L. (V.) panamensis exhibited a significant induction of genes
associated with the tryptophan catabolism and AHR pathways, important regulators of the proinflammatory and
microbicidal response. These findings suggest that strains belonging to the naturally antimony-resistant
subpopulation elicit differential modulation of the human macrophage response compared to the antimony-
sensitive subpopulation. The gene products induced in host macrophages by naturally Sb-resistant and sensitive
subpopulations of L. (V.) panamensis may enable the resistance phenotype as well as treatment failure, thereby
constituting potential therapeutic targets.
We hypothesize that the host cell response elicited by the infection with these distinct subpopulations of
L. (V.) panamensis is a determinant of their natural resistance or sensitivity to pentavalent antimonial drugs. To
evaluate this hypothesis, we will focus on the participation of the tryptophan catabolism and AHR pathways in
the natural resistance of L. (V.) panamensis to antimonial drugs. We will take advantage of the two distinct
subpopulations of L. (V.) panamensis exhibiting natural resistance or sensitivity to meglumine antimoniate to
discern the participation of the host cell response in parasite susceptibility to antimonial drugs. To accomplish
this, we will: i) determine the functional contribution of the IDO/Il4I1-Kyn-AHR pathways induced in primary
human macrophages in natural resistance to antimonial drugs, and ii) identify the genes and interacting pathways
influenced by the IDO/Il4I1-Kyn-AHR pathways that are involved in the distinct macrophage responses
to naturally Sb-resistant and sensitive L. (V.) panamensis and antimony exposure. The ultimate goal of this
project is to identify targetable pathways and gene products among those modulated in the macrophage by
infection with natural antimony-resistant and sensitive parasites. The findings will contribute to the design and
development of macrophage‐targeted therapeutic strategies and therapeutic approaches that optimize treatment
based on the interplay of anti-parasitic treatment and host cell responses.

Public health relevance
NARRATIVE Natural resistance to antimony has been observed in a highly prevalent subpopulation of Leishmania (Viannia) panamensis in Colombia, and infection with these parasites has been associated with failure of treatment with meglumine antimoniate, the first-line treatment for cutaneous leishmaniasis. Parasites belonging to the naturally antimony-resistant subpopulation elicit differential modulation of the human macrophage response compared to those of a sympatric antimony-sensitive subpopulation. We will investigate this response with the ultimate goal of identifying targetable pathways and potential novel host-directed therapies for optimizing the treatment of this neglected disease.